Aging Well with COPD through Geriatrics-Palliative Care

Project Summary
The overall goal of this 5-year K76 resubmission is to support Anand S. Iyer, MD, MSPH to
become a leader in geriatrics-palliative care with the skills to improve the health and well-being
of older adults with chronic obstructive pulmonary disease (COPD). Dr. Iyer is a pulmonologist
and AHRQ-K12 COPD outcomes researcher. COPD is the third leading cause of death for older
Americans and accelerates loss of quality of life and functional independence. Research
priorities of the NIA identify a critical need for innovative geriatrics-palliative care models to
address unmet care needs for older adults, especially those from rural and underserved areas
where COPD is prevalent and palliative care access is limited. However, no geriatrics-
palliative care interventions have been systematically developed and tested for
community-dwelling older adults with COPD. Through this K76, Dr. Iyer will gain advanced
training in: 1) gerontology and geriatrics-palliative care; 2) clinical trials and implementation
science; and 3) leadership development in aging. To support his career development, Dr. Iyer
and his primary mentor, Cynthia Brown, MD, MSPH, have assembled a mentor team of experts
in geriatrics (Seth Landefeld, MD), palliative care-implementation science (Marie Bakitas, DNSc,
APRN), and COPD clinical trials (Mark Dransfield, MD). Dr. Iyer will seek advisement from
international leaders in aging biology (Steven Austad, PhD), lung aging (Victor Thannickal, MD),
geriatrics-palliative care (Christine Ritchie, MD, MSPH), and the aging brain in COPD (Karin
Hoth, PhD). Supported by an AHRQ-K12, Dr. Iyer developed, “EPIC: Early Palliative Care In
COPD”, a 6-month telehealth, palliative-nurse coach-led intervention for COPD patients and
their family caregivers. Preliminary feasibility results in middle-aged COPD patients and their
family caregivers are promising; however, it is not known how EPIC needs to be refined to meet
the needs of older COPD patients, especially the old-old. Guided by Baltes’ Theory of
Successful Aging, this K76 will: 1) Refine the geriatrics content of EPIC by engaging diverse
stakeholder groups of older COPD patients, family caregivers, clinicians, staff, and policy
leaders; and, 2) Conduct a hybrid type-1 effectiveness-implementation pilot randomized
controlled trial of Geri-EPIC plus usual COPD care versus usual COPD care alone to determine
feasibility and acceptability, to refine trial procedures, and to collect preliminary data on Life-
Space mobility to inform a fully-powered trial at the R01 level. Ultimately, this K76 will position
Dr. Iyer to be a leader in geriatrics-palliative care and patient-oriented aging research.

Public health relevance
Project Narrative COPD is the third leading cause of death in older Americans, and older adults with COPD rarely receive proactive geriatrics-palliative care before the end of life. This study will refine and pilot test a telehealth, palliative nurse coach-led geriatrics-palliative care intervention for older adults with COPD and their family caregivers. The results will support a fully-powered randomized controlled trial that will seek to improve the health and well-being of older adults with COPD and their family caregivers.